STUDIES ON THE BIOLOGY AND IMMUNOGENICITY OF MALARIAL SPOROZOITES

Circumsporozoite (CS) proteins have been shown to act as the protective antigens capable of inducing sporozoite - specific immunity in several species of malaria. The gene coding for this antigen in Plasmodium falciparum has been isolated, cloned and incorporated into E. coli. The recombinant protein induces antibodies in mice which react with sporozoites and blocks liver invasion in vitro.